Intrapleural immunotherapeutic nanoparticles for MPE treatment

Abstract
Malignant pleural effusion (MPE) secondary to non-small cell lung cancer (NSCLC) represents a significant
challenge in clinical patient management. MPE is commonly indicative of late stage malignancy and prognosis
of MPE is extremely poor, with a median survival between 4-9 months. The presence of MPE often precludes
surgical intervention, and many patients with MPE are not fit for chemotherapy due to the extremely poor
condition. Current standard of care treatment for MPE is largely palliative. Significant clinical evidence suggests
that the tumor immune microenvironment (TIME) of MPE is profoundly immunosuppressive with abundant tumor-
promoting phenotype of immune cells, which impacts negatively on antitumor immunity. Previous attempts to
improve the TIME involving intrapleural administration of immunotherapeutics have led to some degree of
efficacy. The recent advent of immunotherapy with immune checkpoint blockade (ICB) has aroused renewed
interest in seeking an effective strategy to mitigate the immune cold MPE to enhance the ICB immunotherapy.
Stimulators of interferon genes (STING) pathway has recently been identified to play an important role on
induction of antitumor immunity. As a potent STING agonist, cGAMP ligates STING in cytosol to activate type I
interferons (IFNs) production. However, intrinsic property of cGAMP makes it susceptible to degradation by a
phosphodiesterase that exists in many tissues, and higher levels of the enzyme are identified in malignant
effusions. Moreover, previous studies indicate that activation of STING within tumor–resident antigen-presenting
cells (APCs) is necessary for induction of tumor-specific CD8+T cell immunity. We have recently developed a
novel nanotechonological strategy for APC-targeted delivery of cGAMP (LNP-STING). We assemble LNP-
STING with phosphatidylserine on the outer layer of liposome to facilitate its recognition and uptake preferably
by APCs, and load cGAMP complexed with calcium phosphate to enhance both the loading efficiency and the
release of cGAMP to cytosol, where it binds to STING. In this project, we propose to establish an optimal LNP-
STING for intrapleural administration and test if intrapleural LNP-STING converts the immune cold into
proinflammatory hot MPE. Our central hypothesis is that intrapleural LNP-STING enables to mitigate the
immunosuppressive MPE, thereby setting the stage for favorable response to anti-PD-L1 ICB. We will test the
combination immunotherapy in both MPE mouse models and NSCLC patients’ MPE samples. We propose to
establish an optimal LNP-STING for intrapleural APC-targeted delivery of STING agonist (Aim1). We will then
determine if intrapleural LNP-STING effectively mitigate the immune cold MPE (Aim2). We will last determine if
intrapleural LNP-STING enhances efficacy of the ICB immunotherapy (Aim3). More importantly, we will gain
insights into the biological mechanisms of intrapleural LNP-STING in combination with anti-PD-L1 ICB, which
likely engage both the innate and adaptive anticancer immunity. This work is significant because it may have a
potential to make an impact on the MPE immunotherapy.

Public health relevance
Project Narrative The overarching goal of this translational research project is to develop a new immunotherapeutic nanoparticle for intrapleural administration, aimed at mitigating the immune cold environment in malignant pleural effusion (MPE) to enhance therapeutic efficacy of anti-PD-L1 immune checkpoint blockade (ICB). Intrapleural delivery of antigen presenting cells (APCs)-targeted nanoparticle loaded with STING agonist (LNP-STING) is expected to elicit APC-mediated immune sensing of tumor antigens and cross-priming of effector T cells, thus setting a stage for favorable response to anti-PD-L1 ICB. We will test the combination immunotherapy of intrapleural LNP- STING plus anti-PD-L1 in vivo in a mouse model of MPE, and ex vivo with clinical MPE samples, and importantly, gain insights into the immunobiological mechanisms of LNP-STING interacting with the complex tumor microenvironment in MPE.